Role of homologous recombination in the replication stress response

PROJECT SUMMARY/ABSTRACT FROM PARENT AWARD
Precise replication of DNA is required to maintain genome stability. Replication forks face many obstacles from
Endogenous and exogenous sources that result in fork stalling or breakage threatening integrity. The double
strand break repair pathway, homologous recombination, has critical roles at stalled replication forks
independent of double strand breaks. The importance of this pathway is highlighted by patients with inherited
chromosomal instability orders and cancer predisposition syndromes. Although an intense area of study, how
recombination proteins function at replication forks are poorly understood. A comprehensive understanding of
the replication response is critical for the understanding the molecular mechanisms of human disease and to
lead to development of novel therapeutics for patients harboring mutations in replication response genes. The
long-term goal of the PI to elucidate the roles of recombination proteins in the replication stress response. In
support of this goal, the PI and laboratory have established a powerful-separation-of-function allele of the central
recombination enzyme, RAD51 and uncovered a novel role for a recombination accessory protein. The
successful completion of this work will lead to a better of understanding of the role recombination proteins play
at stalled replication forks and how protect the integrity of the genome.

Public health relevance
PROJECT NARRATIVE The homologous recombination pathway plays critical roles during the response to replication stress and disruption of the response leads to a wide variety of human diseases. We are elucidating the molecular mechanisms of recombination proteins at stalled replication forks. Our discoveries will lead to a better understanding of how disruption of the pathway results in human disease potentially leading to identification of novel targets for therapeutics for recombination-deficient inherited disorders and cancer.